BLRD Research Career Scientist Award Application

Inflammation is the body's attempt at self-protection to remove harmful stimuli and begin the healing process.
Chronic inflammation can eventually cause several diseases and conditions, including cancers, rheumatoid
arthritis, atherosclerosis, and plays a role in heart disease. The overarching goals of nominee’s research involve
elucidating molecular underpinnings of cell growth/survival and death/apoptosis with particular reference to
cancer, atheroscleroscosis, and cardiovascular hypertension.
The American Cancer Society estimates highest percent of new cases and mortality resulting from lung
and breast cancers in females, while prostate and lung cancers account for highest percentage of new cases
and associated mortality among men. Overall incidence rates and mortality due to lung and breast cancers have
decreased over last decade partly due to advances in diagnosis and therapeutics, particularly targeted
therapeutics for a number of cancers including the non-small cell lung cancers (NSCLCs). However, adaptive
genetic alterations and mutations in cancers contribute to therapy failures and relapses in clinic occur that often
result in emergence of resistant, hard to treat disease, and warrant development of new therapeutic strategies
to overcome drug resistance and improve therapeutic outcomes.
By utilizing a functional gene-knockout approach the nominee identified a novel, apoptosis inducing
protein termed CARP-1/CCAR1 (J. Biol. Chem. 278: 33422-33435, 2003). CARP-1 regulates apoptosis
signaling induced by diverse therapeutics such as Adriamycin, Etoposide, and Gefitinib (Oncotarget 6(9): 6499-
510, 2015). Following CARP-1 discovery, the nominee conducted a chemical-biological approach to identify
novel small molecule CARP-1 Functional Mimetic (CFMs) compounds (J. Biol. Chem. 286 (44): 38000-38017,
2011). CFMs inhibit growth of therapy-resistant triple-negative breast cancers (TNBC) and non-small cell lung
cancers (NSCLCs) in part by inducing CARP-1-dependent apoptosis (Oncotarget, 7(45): 73370–73388, 2016;
8(62):104928-104945, 2017; 9(51): 29680-29697, 2018). During RCS funding, nominee made a fundamental
observation that CARP-1 interacts with NF-κB kinase subunit gamma (IKKγ). This interaction functions to
activate NF-κB-dependent cell survival and growth in genotoxic chemotherapy-treated cancer cells (J. Biol.
Chem. 295: 3532-3552, 2020). Targeting of IKKγ-CARP-1 binding prevents therapy-induced NF-κB activation.
On the basis of this finding nominee discovered new compounds, termed selective NF-κB inhibitors (SNIs), that
target IKKγ-CARP-1 binding to attenuate therapy-induced survival pathways and enhance efficacy of cisplatin in
preclinical tumor models of breast and renal cancers. Given that cisplatin is widely used anti-cancer therapeutic
in BRCA-mutant breast, non-small cell lung, and kidney cancers, SNI compounds will provide a novel avenue to
improve chemotherapy efficacy and attenuate emergence of drug-resistant cancers. The nominee’s long-term
goal is to elucidate molecular mechanisms of therapy resistance in TNBC and NSCLCs, and utilize this
knowledge to develop novel, safer and effective anti-cancer modalities. In this context CFMs and SNIs or their
derivatives are anticipated to facilitate development of strategies for effective treatment of TNBC, NSCLCs, and
other cancers in the VA healthcare system and beyond.
Prevalence of atherosclerotic reno-vascular hypertension is rising. Renal artery stenosis occurs in 28%
of veterans undergoing cardiac catheterization with a greater than 3-fold risk in those over age 65. There is an
alarming burden of cardiovascular and renal morbidity and mortality with attendant increases in direct medical
costs, loss of productivity and quality of life in our Veterans with hypertension. The nominee continues to have a
productive collaboration with Detroit VA clinician-scientist to study the molecular and behavioral mechanisms of
the angiotensin-endothelin signaling in Reno-vascular model. In RCS funding period, nominee served as a co-
investigator of the two VA funded Merit applications that investigated mechanisms of reno-vascular hypertension.

Public health relevance
The nominee’s research investigates molecular mechanisms of disorders associated with chronic inflammation such as breast and lung cancers, and reno-vascular hypertension. These diseases are known to cause significant morbidity and mortality with attendant increases in direct medical costs, loss of productivity and quality of life in our veterans of all ages. The research projects are intended to elucidate mechanisms of drug resistance in human triple-negative breast (TNBC) and non-small cell lung cancers (NSCLC), and exploit this knowledge to design, synthesize and optimize novel compounds that inhibit therapy-induced survival, and activate CARP-1 and apoptosis in naïve and drug-resistant cancer cells. CARP-1 and the novel CFM and SNI compounds were discovered by the nominee through the VA supported Merit funds. The nominee is also productively collaborating with Detroit VA clinician to investigate mechanisms of reno-vascular hypertension, and served as co-investigator on two, VA Merit proposals. Rishi - 1